PROGRAM LEADERS

Program Directors Cancer Centers exist to foster cancer-focused research, in part through the creation of formal Programs. A program comprises the activities of a group of investigators who share common scientific interests and goals and participate in competitively funded research. The 13 programs in the UMCCC Cancer Center Support Grant are highly interactive and lead to exchange of information, experimental techniques, and ideas that enhance the individual productivity of scientists and often result in collaborations and joint publications. Ultimately, the success of Programs is measured by the emergence of productive collaborations. The 13 programs are: Cancer Genetics, Cancer Cell Biology, Molecular Therapeutics, Radiation Sciences, Molecular Imaging, Leukemia/Lymphoma-BMT, Breast Oncology, Prostate/Urologic Oncology, Gastrointestinal Oncology, Childhood Cancers, Head and Neck Oncology, Biomedical Prevention and Socio-Behavioral.